Disparities in Processes and Outcomes of Care Across Asian/Pacific Islander Populations at Childbirth

Racial/ethnic disparities in the quality of care provided to mothers and infants during the birth hospitalizations
result directly in avoidable death and morbidity. Asian American and Pacific Islanders (AAPI) represent the
fastest growing racial/ethnic group (25% living in California) and they experience significant disparities in several
areas that are robust and merit policy and clinical attention. Unfortunately, research of AAPI populations suffers
considerable limitations. First, few studies report on AAPI populations and those that do, usually aggregate to
“Asian” or “Asian American and Pacific Islander”, masking the biological and sociocultural heterogeneity. Sec-
ond, sociodemographic and neighborhood factors are rarely available for studies of hospital quality at childbirth.
Third, lack of multilevel adjustment undermines the validity of comparative assessments of quality by penalizing
hospitals that care for vulnerable populations.
To understand disparities in care processes and outcomes for AAPI mother/infants, we will undertake a compre-
hensive appraisal of the multilevel factors associated with quality of care during the birth hospitalization, promote
fairer comparisons by making sociodemographic and neighborhood influences explicit; and assess key areas of
quality using key performance metrics for care provided to mothers, low-risk newborns, and infants born very
low-birth-weight (VLBW; <1500g).
Innovative methods include leveraging our unique multilevel data sources to provide comprehensive assess-
ments of hospital quality for AAPI populations with unprecedented granularity, assessing quality via key indi-
vidual and composite measures, and using a mixed-methods approach to provide unique insights into the
mechanisms by which sociocultural and neighborhood factors optimize or degrade quality. Specific aims:
1) Test for disparities in care processes and outcomes among AAPI mothers and infants and identify associations
with patient and neighborhood level social risk factors;
2) Assess the impact of hospital performance on care processes and outcomes of AAPI maternal/infant popula-
tions; and
3) Understand the birth and birth hospitalization experiences of AAPI populations alongside drivers of disparities
in care processes and outcomes.
An exceptional strength of our proposal is our ability to leverage the unique infrastructure of the California Peri-
natal and Maternal Quality Care Collaboratives. Building on our prior work in linking complimentary high-quality
clinical, administrative, and survey-based data sets containing multi-level factors, we will study a large popula-
tion-scale AAPI sample of 1.6 million mothers and newborns (including ~8,000 VLBW infants) in 238 maternity
hospitals and 138 neonatal intensive care units in California between 2011-23. Results of this proposal are
expected to have an immediate positive impact because in leveraging our expertise as active quality improve-
ment organizations, they are designed to identify pragmatic areas where hospitals and communities can improve.

Public health relevance
Narrative Asian American and Pacific Islander (AAPI) populations are an extremely diverse group, representing 30 different countries (e.g., Filipino, Chinese, Indian, Vietnamese, Japanese, etc), and in the United States have different immigration histories, cultural traditions, and medical risks, and live in segregated neighborhoods. AAPI mother and infant populations have been understudied, but without detailed knowledge of these populations, mothers and infants will receive suboptimal care during childbirth, which may result in unnecessary mortality or lifelong morbidity. We propose to address this gap, setting the stage for reducing disparities among AAPI mothers and infants.